Investigating the molecular mechanisms of growth in GNAS mutant pancreatic cancer.

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is the fourth leading cause of cancer death in the United States with
five-year survival after detection is less than 10%. The subset of PDA arises from Intraductal papillary mucinous
neoplasm (IPMNs) precursor lesions are distinguished by recurrent activating mutations in GNAS, that encodes
G-protein Gαs, and induces cyclic-AMP (cAMP) signaling. GNAS is mutationally activated and amplified
pancreatic and many other human tumors, yet its oncogenic functions remain unclear. Therefore, understanding
the function of mutant GNAS will provide disease mechanisms and give opportunities to treat PDA even in their
early stages. To understand the function of oncogenic GNAS we established a doxycycline-tunable mouse model
and showed that mutant GNAS cooperates with oncogenic KRAS to initiate IPMNs that progress to invasive
PDA upon p53 loss. GNAS remains critical for the maintenance of established tumors, via a protein kinase A
(PKA)-dependent network and resulting inhibition of salt-inducible kinases (SIK1-3). We demonstrated that this
network prominently reprograms metabolic pathways which are potential alternative sources of TCA cycle
metabolites, respiratory substrates (NADH) and fatty acid intermediates that can support the growth of GNAS
mutant tumors. Importantly, GNAS-mutant cancer cells are specifically sensitive to the inhibition of these
pathways compared to GNAS-wt tumors. These results establish mutant GNAS as a novel tumor maintenance
driver, uncover the underlying PKA-dependent program, establish SIKs as major tumor suppressors, and
demonstrate unanticipated metabolic heterogeneity fueling subsets of pancreatic cancer. Based on our
published and unpublished supporting data, the overarching goal of this proposal is to understand the roles of
critical downstream targets of GNAS-PKA signaling that control the expression of proliferation and metabolic
genes. Our research will also illuminate how mutant GNAS regulated expression of a keto dehydrogenase
generate biosynthetic and bioenergetic intermediates to support tumor growth. Finally, our study will interrogate
the regulation of respiratory activity and its requirement in GNAS mutant pancreatic cancer. This study will
leverage advanced methods and unique tools, including global transcriptomic analysis and isotopomer-based
metabolic profiling in genetically defined mouse and human organoid systems, preclinical pancreatic cancer
animal models, relevant patient-derived xenograft systems and primary samples. Our research will provide
understanding of the unique biology of mutant GNAS and points out targetable vulnerabilities in genetic subsets
of pancreatic tumors.

Public health relevance
PROJECT NARRATIVE A significant subset of pancreatic cancer patients harbors gain-of-function mutations and amplification of GNAS(Gα-s), however the function of mutant GNAS has remained elusive. The goal of this proposal is to understand how mutant GNAS driven signaling couple the core transcriptional and metabolic circuitry to propel tumor growth. Here we will use advanced organoid models, genetically engineered animals, patient-derived xenografts combined with global transcriptomics, isotopomer-based metabolic labeling and advanced microscopy to decipher oncogenic network of mutant GNAS in pancreatic cancer.